Synaptic Actions of Amphetamine in the Striatum

Project summary
Addictive psychostimulants such as amphetamine act at dopamine synapses in the striatum. Presynaptic
amphetamine action drives dopamine release via activity-dependent and activity-independent mechanisms.
Dopamine acts on multiple dopamine receptors that are differentially distributed on striatal neurons. Beyond
this volume transmission, dopamine neurons engage in synaptic transmission that is operative on a fast time
scale, compared to volume transmission, and involves not only dopamine, but also GABA and glutamate. This
project focuses on these synaptic connections as a novel substrate for psychostimulant action. The synaptic
transmission exerts excitatory effects through dopamine D1 receptors, ionotropic and metabotropic glutamate
receptors, and inhibitory effects through dopamine D2 receptors and GABAA receptors. While dopaminergic
and GABAergic synaptic connections are widespread, glutamatergic connections are concentrated in the
medial nucleus accumbens and the anterior lateral dorsal striatum. Synaptic connections to cholinergic
interneurons are the strongest, most complex, involving dopamine, GABA and glutamate. Remarkably
glutamate cotransmission is abrogated by amphetamine administration, and abrogation of glutamate
cotransmission attenuates psychostimulant responsiveness. The guiding hypothesis is that amphetamine-
induced plasticity of a subset of dopamine neuron synapses is critical for driving the striatal circuitry towards
the addicted state, particularly dopamine neuron synapses distinguished by glutamate cotransmission. The
three specific aims are to: <1> Determine quantitatively amphetamine-induced plasticity of dopamine neuron
synaptic connections to cholinergic interneurons in striatal subregions identified by synaptic connectivity-based
clustering. <2> Determine direct synaptic effects of amphetamine on dopamine neuron synaptic transmission
in striatal subregions distinguished by glutamate cotransmission. <3> Determine amphetamine effects on
dopamine neuron terminal activity during amphetamine-induced behaviors. This project will advance
understanding of the synaptic substrate of amphetamine action in the striatum, revealing loci of drug-induced
plasticity that will inform the pharmacotherapy of addiction.

Public health relevance
Narrative Addictive psychostimulants such as amphetamine act in the striatum at the synapses of dopamine neurons, particularly those utilizing glutamate as a cotransmitter. Elucidating how amphetamine affects these synapses will provide new insight into addiction mechanisms and potential treatments.